Chemoenzymatic Synthesis, Mode of Action and Evolution of Natural Product-based Macrocycles

Chemoenzymatic Synthesis, Mode of Action and Evolution of Natural Product-based Macrocycles
(Parent Grant)
Natural peptide macrocycles are promising next-generation therapeutics, due to their abilities to bind
to challenging protein targets, such as protein interfaces and transcription factors. The goal of our lab is to
use insights and chemistries from natural product biosynthesis to facilitate the discovery and development of
new natural product-like peptide macrocycles. We will use a combined chemical and enzymatic
approach for synthesis and efficient benchtop evolution of highly constrained peptide macrocycles similar to
those used in nature. Over the next five years, these efforts will be divided between two main project areas. In
the first project area, we will use enzymes take from ribosomal peptide natural product biosynthetic pathways
to modify mRNA display libraries of peptides. Essential to this work will be the continued development of
display-coupled assays for enzyme modification that will be used to elucidate enzyme promiscuity. In the
second project area, these libraries will be used to select novel macrocyclic peptide inhibitors against a
focused set of therapeutic targets and complexes. Structural characterization of target-ligand complexes
will uncover principles of macrocycle engagement and elucidate new strategies for targeting these
otherwise challenging interfaces. This work is expected to yield new avenues and technologies for
development of peptide macrocycle-based therapeutics.

Public health relevance
Project Narrative: (Parent Grant) Natural product biosynethtic pathways make complex, synthetically challenging molecules that inhibit high value therapeutic targets. Here we are using a newly discovered classes of enzymes from natural product pathways to make new therapeutic scaffolds. These studies will provide new chemoenzymatic methods for preparation of complex, natural product-like macrocycles and new insights into means of inhibiting cancer by targeting challenging protein interfaces.